UPDATING THE RBVI ANNUAL REPORT SYSTEM

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. An updated and improved online system has been developed for the collection and compilation of information used to produce the RBVI Annual Report, submitted each year to the NIH. The system uses a web-based interface and several Python programs to maintain project and investigator data in an XML-formatted data file. The system works with a variety of web browsers and has proven popular with RBVI users.